Toward Patient-Specific Computational Modeling of Tricuspid Valve Repair in Hypoplastic Left Heart Syndrome

PROJECT SUMMARY/ABSTRACT
Hypoplastic left heart syndrome (HLHS) is characterized by maldevelopment of the left heart and affects over
1000 live-born infants annually in the U.S. Neonates with HLHS undergo three staged open-chest reconstruction
surgeries to create normal blood flood through the heart. However, twenty-five percent of HLHS Fontan patients
(survivors who completed the three-staged surgeries) develop tricuspid regurgitation and are facing a significant
risk of death and heart failure. Tricuspid valve intervention may treat valve leakage, but the surgical outcomes
and long-term repair durability remain suboptimal due to the lack of mechanistic insights into the biomechanical
and morphological factors that influence the tricuspid valve function. Prior work on image-derived atrioventricular
valve finite element analysis has offered a sound computational framework for dissecting the relationship
between valve structure and its biomechanical function. There is, however, a paucity of ex vivo and animal
models of HLHS. As such, quantifying representative tricuspid valve tissue properties for patients in the HLHS
population remains a challenge. This limits patient-specific clinical translation of finite element analysis and
undermines the potential of computational analysis for guiding improved surgical decisions in HLHS.
The objectives of this proposed project are to 1) discover representative tricuspid valve tissue properties
in the HLHS population using physics-informed machine learning, and 2) to evaluate the relationship between
tricuspid valve anatomic feature and the associated biomechanical indices (i.e., leaflet stress, strain, and
coaptation height and gap area). We will identify the tricuspid valve leaflet tissue properties for a subset of HLHS
tricuspid valves (n = 10 with trivial to mild regurgitation, n = 10 with moderate to severe regurgitation) and
establish an empirical distribution of the tissue constants. This will inform the level of tissue heterogeneity within
this subset of the HLHS population. We will also identify the association between anatomic features and
biomechanical indices for this subset of the HLHS population using 3D echocardiography-derived finite element
analysis. This will guide the design of customized valve repairs to improve surgical outcomes for individual
patients.
K25 Candidate Dr. Wu completed a Ph.D. in Structural Engineering at Cornell University. The proposed
research and training plan will provide her with an initial exposure to biomedical research as she prepares for an
independent research career in translational cardiovascular science. Further, this K25 will offer her the
opportunity to cultivate a strong knowledge base in cardiovascular disease and treatment procedures, as well
as expand her expertise in advanced computational modeling skills, within an immersive clinical environment.
Dr. Wu’s exceptional mentoring team is uniquely positioned to guide her through her development toward
becoming an independent investigator and leader in the multidisciplinary study of computational science
engineering and cardiovascular science.

Public health relevance
PROJECT NARRATIVE Tricuspid regurgitation is associated with a significant risk of morbidity and mortality in children with Hypoplastic Left Heart Syndrome (HLHS). However, the underlying mechanisms of tricuspid regurgitation remain unclear given the limitations in obtaining appropriate tricuspid valve tissue properties and morphologies. The proposed study will leverage physics-informed machine learning and 3D echocardiography- derived finite element modeling to develop patient-specific tricuspid valve models that will be used to delineate the cause of tricuspid valve regurgitation in a small cohort of HLHS patients.